Frontiers in Alzheimer's and Aging Research Experiences

PROJECT SUMMARY
This renewal of R25 AG043365-10 for NIA’s “Advancing Diversity in Aging Research through Undergraduate
Education (ADAR)” program, now re-entitled: “Frontiers in Alzheimer’s and Aging Research
EXPERIENCES” (FrA2RE), requests support for five cohorts of ≥12 promising undergraduates annually who
“…are eligible…if they are from economically, socially, culturally, or educationally disadvantaged backgrounds’
(responsive to PAR-20-317). FrA2RE concentrates on Structured Research Experiences and essential
mentoring to launch and sustain careers within NIA’s portfolio. Experts investigating Alzheimer’s disease and
Related Dementias (ADRD) and Aging partner with selected undergraduate trainees (applicants:
acceptances is 7¼ :1), forming Trainee: Mentoring Dyads. The ADRD and aging fields continue to grow
swiftly, yet there are too few laboratories led by URM scientists and too few new URM trainees. FrA2RE is
directed by Gerald Schatten, PhD (Pittsburgh), with Co-Investigators Laura Niedernhofer, MD, PhD,
(Minnesota), George Langford, PhD, Director of the American Society for Cell Biology’s [ASCB] new Pair-Up
program, and Research Experiences Coordinator Calvin Simerly, PhD, (Pitt) forming the Executive
Committee. Overseen by the Scientific Advisory Board (SAB), co-chaired by Winston Thompson, PhD,
(Morehouse School of Medicine: MSM) and Melissa Walls, PhD (Indigenous Professor at JHU-Duluth), they
ensure that the next generation of undergraduate trainees succeeds in their career choices. FrA2RE begins
with an introductory ‘Meet and Greet’ weekend, partnering with Co-I George Langford’s Pair-Up at the MBL
(Octobers). Then after ≥ year of structured research experiences, each year’s cohort completes the program
with a Reunion held at the annual NIA’s ADAR summit-GSA congress (Novembers). FrA2R graduates,
progressing in ADRD and aging-research careers, self-identify as 34% AA/B; 38% as Hispanic American; 71%
are women, 48% are from URM institutions. FrA2RE anticipates many recruits from Tribal Nations. Five aims
are proposed: I. Sponsor meaningful Structured Research Experiences. II. Ensure Diversity, Equity,
Inclusion, and Accessibility (DEIA) representation. III. Demystify oversight requirements by training in
responsible conduct of research (RCR). IV. Provide career planning and choices, particularly the possibility of
them joining the NIA-NIH’s research workforce; and V. Evaluate, improve, and monitor FrA2RE’s strengths
and avoid weaknesses with unbiased, quantitative, independent mechanisms. Thus, FrA2RE will continue to
enhance and expand the research careers of the most promising scientists, while ensuring their investigations
comply with NIH’s policy of ‘Inclusion of Women, Minorities, and Individuals Across the Lifespan,’ particularly
NIA’s focus on improving the diagnoses, health, and well-being, among the elderly and those suffering from
Alzheimer’s Dementia and Related Disorders and their caregivers, and biological, clinical, behavioral,
social, aspects of aging, as well as helping to rectify inequities and increasing diversity.

Public health relevance
NARRATIVE This renewal of R25 AG043365-10 (responsive to PAR-20-317) for NIA’s “Advancing Diversity in Aging Research through Undergraduate Education (ADAR)” program, now re-entitled: “Frontiers in Alzheimer’s and Aging Research EXPERIENCES” (FrA2RE), requests support for five cohorts of ≥12 promising undergraduates annually who “…are eligible…if they are from economically, socially, culturally, or educationally disadvantaged backgrounds’. FrA2RE concentrates on Structured Research Experiences by matching under-represented minority Trainees with Expert Mentors, creating a Dyad investigating Alzheimer’s disease and Related Dementias (ADRD) and Aging along with essential mentoring to launch and sustain careers within NIA’s portfolio, and is well justified since while the ADRD and aging fields continue to grow swiftly, and there are still too few laboratories led by URM scientists and too few new URM trainees. In so doing, FrA2RE innovatively enhances and expands the biomedical research careers of the most promising scientists, while ensuring their investigations comply with NIH’s policy of ‘Inclusion of Women, Minorities, and Individuals Across the Lifespan,’ particularly NIA’s focus on improving the diagnoses, health, and well-being, among the elderly and those suffering from Alzheimer’s Dementia and Related Disorders and their caregivers, and biological, clinical, behavioral, social aspects of aging, as well as helping to rectify inequities and increasing diversity.